Metagenomic Evaluation of the Oral Flora of Pediatric HIV Patients

ABSTRACT Pediatric HIV disease remains a great challenge globally, particularly in the developing world. Oral disorders cause significant morbidity and mortality in HIV-infected infants, children, and adults. Oral microbiota likely play a significant role in HIV disease-associated oral disorders. Further, pediatric HIV represents an excellent model system for the study of immunodeficiency-associated changes in oral microbiota because the disease is well- defined, with clearly established degrees of immune deficiency that are associated with significant clinical outcomes, and the abundant availability of a control group (healthy children and non-immune suppressed HIV- infected children). Pediatric HIV-associated oral disorders differ from those of adults, and the oral microbiota of children changes dramatically during development, due to the initial acquisition of oral flora by the uncolonized newborn, the changes in diet that accompany weaning and the adoption of an adult diet, and the development of dentition, from edentulous, to primary, mixed, and permanent dentition. Hence, any understanding of the involvement of the oral microbiota in the pathogenesis of HIV-associated oral disorders in children cannot rely on studies conducted in adults. We propose to assemble a cohort of HIV-infected children who are highly, moderately, and non- immune compromised who have primary, mixed, and permanent dentition, and a comparison cohort of normal children. Examining these cohorts, we will 1) Determine the species composition and rank abundance of the oral microbiota of a cohort of HIV-infected children with no/low, moderate, and severe degrees of immunosuppression and a normal control cohort using deep 16S rRNA gene analysis, 2) Determine the microbial community gene content (metagenome) and predicted metabolic capabilities of the oral microbiota of HIV-infected children and a normal control cohort using metagenomic shotgun sequencing, and 3) Determine the portfolio of expressed genes (metatranscriptome) of the oral microbiota of HIV-infected children and a normal control cohort. We will use the 454 pyrosequencing platform and a sophisticated bioinformatics and statistical analysis pipeline to study how the microbial community and community functional characteristics differ in immunosuppressed and non-immunosuppressed HIV-infected children and normal infected children and to understand how the functional abilities of the oral microbiota changes during development. The data obtained in the proposed study will provide key information to enable understanding of the influence of HIV-associated immunosuppression on the oral microbiota, the influence of immunosuppression generally on the oral microbiota, and the effects of dentition development on the microbiota. The information will be essential for the understanding of the pathogenesis of HIV-associated oral disorders. The data will also provide key insights into the development of the oral microbiota of normal children.

Public health relevance
PROJECT NARRATIVE (Lay Summary) While transmission of HIV from mother to child has largely been interrupted in the developed world, it remains a profound public health problem in the developing world. Most of those HIV-infected children suffer from oral complications of their HIV infection. The causes of many of the complications remain unknown, but many likely have a microbiologic origin. The oral complications of HIV seen in children differ from those seen in adults. The oral microbiology of children also differs significantly from the oral microbiology of adults because the biology of the mouth changes dramatically as children grow into adults. The mouths of newborns are sterile, eventually changing as the child grows, experiences weaning and begins to eat different foods, and develops first deciduous and then eventually permanent teeth. Any attempt to understand the oral complications of HIV infection in children will need to address the special features of the developing oral biology of children. So far, the oral microbiology of HIV patients, including HIV-infected children, has been studied mainly with conventional culture techniques, which can identify only a small fraction of the microbes living in the mouth, so we know very little about the microbes that probably cause the oral complications of HIV. We hypothesize that we can better understand the causes of the oral complications of HIV by using newly developed molecular techniques that do not require conventional microbiologic culture and that this understanding will help us devise new treatments for the oral complications of HIV infection. These new molecular techniques enable us to learn the identity of the microbes living in the mouth without having to grow them in culture, catalogue the genes of the microbes, which provides insights into the metabolic capabilities of the microbes, and examine what genes the microbes are expressing, which shows what the microbes are trying to accomplish. We propose to study the microbes living in the mouths of highly immunosuppressed, moderately immunosuppressed, and non-immunosuppressed HIV-infected children with primary teeth, mixed primary and adult teeth, and only adult teeth using the new molecular techniques. We also propose to study normal children with similar mixes of primary and adult teeth, as a point of comparison. Our proposed studies should enable us to understand the causes of the oral complications of HIV infection in children, and perhaps the oral complications of other children with immunosuppression, such as children with genetic causes of immunodeficiencies or immunodeficiencies caused by treatments such as cancer chemotherapy. This knowledge should help us design better treatments for these children, and potentially for adults. The studies should also help us understand how the microbes present in the mouths of normal children change during development.